TNF alpha and Recovery from Alcoholic Liver Injury

Morbidity and mortality in alcohol-related liver diseases (ALD) are caused by severe alcohol-induced
steatohepatitis (SAH) and cirrhosis (AC). Effective therapies are lacking because the mechanisms driving the
pathogenesis and progression of SAH and AC are unclear. This research program has evaluated the general
hypothesis that bad outcomes of alcohol-induced liver injury result from deregulated repair mechanisms that
cause defective regeneration of mature hepatocytes. Our prior results indicate that effective liver regeneration
requires reactivating fetal programs to nurture the outgrowth of liver progenitors but then silencing these
programs, so the liver matures appropriately. Thus, we will continue to evaluate the hypothesis that ALD
progresses because mechanisms controlling when fetal programs are switched ON and OFF in adult liver cells
are dysregulated. We have evidence that liver failure in human SAH results from the over-activation of fetal
programs. Conversely, our pre-clinical data suggest that cirrhosis evolves when adult programs are not
suppressed sufficiently for injured livers to regenerate. RNA Binding Proteins (RBPs) dynamically control the
stability, translation, and splicing of mRNAs encoded by liver genes. Thus, we propose that RBPs critically
control adult-fetal “switching” in hepatocytes during ALD. To identify the repertoire of RNA binding proteins, RNA
splice variants, and liver genes that change in response to alcohol-induced liver injury, we coupled high-
resolution sequencing of liver RNA with single-cell transcriptomics and chromatin accessibility analyses. ESRP2
was identified as one of the most down-regulated hepatocyte RBPs in human SAH. ESRP2 regulates the splicing
of ~20% of hepatocyte RNAs, generating splice variants that encode functional differences in proteins that control
hepatocyte proliferation and differentiation. We have reported that ESRP2 is critically important for switching on
the adult program in developing livers and that over-expressing ESRP2 blocks adult liver regeneration. Our new
data show that human SAH livers are enriched with fetal splice variants of ESRP2 targets that alter the activity
and cellular localization of their encoded proteins. We reported that TNF and IL1 (critical cytokines in ALD
pathogenesis) regulate both ESRP2 expression and adult-to-fetal “switching” in hepatocytes. Our ongoing
studies indicate that manipulating ESRP2 exacerbates liver damage in mouse models of steatohepatitis, further
supporting the concept that ESRP2 misregulation is an important driver of deregulated repair mechanisms in
ALD. Iterative analyses of human liver samples and mouse models of liver injury and repair will continue during
the next funding cycle. Based on present data, we will prioritize studies to determine how ESRP2-regulated
RNA splicing events control hepatocyte responses to alcohol-induced injury, delineate how these adapted
hepatocytes reconfigure other liver cell communities to dictate ALD outcomes, and define mechanisms that
regulate ESRP2 expression, thereby revealing novel therapeutic targets to improve recovery from ALD.

Public health relevance
Patients already have alcoholic liver disease (ALD) when they present for medical care. Thus, a primary goal of treatment is to expedite liver repair. Successful repair regenerates mature liver cells without causing liver failure, cirrhosis, or cancer. Our research is significant because it is revealing how to optimize liver repair and thus, recovery from ALD.